Project 4-Modulating Innate Immunity to Overcome Resistance to PD-1/PD-L1 Blockade

PROJECT 4: PROJECT SUMMARY
Dramatic progress has been made in recent years in treating patients with advanced melanoma, particularly with
inhibitors of PD-1 or PD-L1, resulting in prolonged survival and a sharp rise in the number of patients living with
metastatic melanoma. However, over half the patients do not respond to PD-1/-L1 inhibitors, and tumor regrowth
is seen in about half the patients by two years. Thus, there is great need to understand mechanisms of
resistance and to develop new approaches to overcome resistance. A well-documented mechanism of
resistance to PD-1/L1 inhibitors is paucity of tumor infiltrating T cells (TILs). We have found that targeting tumor
associated macrophages by inhibition of the colony stimulating factor-1 receptor (CSF1R) results in tumor
regression in a T cell independent fashion and induces increased TNFα, IL-1β, IFNγ expression and neutrophil
recruitment. Similarly, antibodies that activate CD40 also result in macrophage modulation and tumor regression
and synergize with CSF1R. When used together in mice, these treatments stimulate a T cell-dependent anti-
tumor response. We hypothesize that triple therapy (inhibitors of CSF1R and PD1 with CD40 agonists) may be
even more effective at eliciting anti-tumor responses to tumors that were at one time poorly infiltrated and/or
recognized by T cells. We will test the key hypothesis that stimulating both innate and adaptive immunity
leads to more robust anti-tumor immunity than those that preferentially target T cells or myeloid cells
alone. We will utilize a series of novel immune competent murine models of resistance to PD-1/PD-L1 inhibitors
generated at Yale with driver mutations that mimic human melanomas (e.g., BrafV600E, NrasQ61R, loss of Cdkn2a,
Pten, p53, and gain of β-catenin). We will study the effects of CSF1R inhibitors and CD40 agonists with and
without PD-1 inhibitors to determine activity and toxicity of doublet and triplet regimens in murine models with
various genetic backgrounds (Aim 1). In Aim 2 we will study the mechanisms of sensitivity or resistance to the
various combinations to facilitate predictive biomarker studies for humans treated with these regimens. We will
conduct a phase I/IB clinical trial (Aim 3) of a CSF1R mAb in combination with a CD40 agonist with concurrent
dose escalation of a triplet regimen that will include the addition of nivolumab. Expansion of the optimal regimen
will be conducted using a Simon two stage design. Patients eligible for the trial will have advanced melanoma
that has progressed on prior PD-1/PD-L1 based regimens. Tumors from patients treated on this trial will be
characterized for tumor associated macrophage subsets and TIL subsets using state-of-the-art technologies.
The collaborative team, availability of clinically-relevant animal models and access to patients and their tumors
will thus enable us to go back and forth between the clinic and the lab, facilitating personalized approaches for
patients with tumors poorly responsive to PD-1/PD-L1 inhibitors. Results from these studies will be helpful for
overcoming resistance to PD-1/PD-L1 inhibitors in other tumor types as well.

Public health relevance
PROJECT 4: PROJECT NARRATIVE While newer immune therapies, particularly inhibitors of PD-1, have revolutionized care for patients with metastatic melanoma, over half of patients do not respond and many develop acquired resistance to these drugs over time. Here we propose a series of experiments using novel immune competent animal models to further study additional drugs that enhance anti-tumor responses. We also propose studies of tumors from patients who developed resistance to PD-1 and a clinical trial with newer drug combinations, with the goal of overcoming resistance to PD-1 inhibitors.